Consumer Assessment of Healthcare Providers and Systems (CAHPS) VI

PROJECT SUMMARY/ABSTRACT
The Consumer Assessment of Healthcare Providers and Systems (CAHPS®) VI project will advance the
Agency for Healthcare Research and Quality (AHRQ) CAHPS mission of improving patients’ experiences with
health care overall and equity of care by developing and evaluating strategies for survey measurement,
reporting and quality improvement. We propose a 5-year effort to advance the science and practice of patient
experience assessment, ensure relevance to current health service delivery and implement best survey
practices, further the science of reporting, and evaluate CAHPS quality improvement efforts. We will develop
survey items targeted at perceived bias/discrimination, communication with non-English language preferring
patients, and functional limitations. In addition, we will use stakeholder consensus methods to update the
CAHPS health plan 5.0/5.1 and Clinician and Group 3.0/3.1 surveys. Moreover, we will evaluate alternatives to
the standard CAHPS modes of data collection and conduct analyses of non-response patterns to elucidate the
combination of mode of administrations best suited for racial and ethnic minorities. We will assess racial/ethnic
bias in Amazon Comprehend and Google’s AutoML natural language processing of narrative data and
evaluate quality improvement communication strategies designed to improve the experiences of care of
patients of safety net providers.
The project team is well suited to achieving the study objectives given its prior accomplishments and
established working relationships. The work is innovative and designed to (1) refine CAHPS surveys and
enhance their use via data collection methods that improve response rates, (2) facilitate reporting and use of
CAHPS survey data, and (3) strengthen efforts to improve experience with health care in the United States
(U.S.). It builds upon the team’s past accomplishments as part of the CAHPS consortium to ensure that the
quality of health care is optimized for the socioeconomically disadvantaged and those for whom Spanish-
language is preferred. The project contributes substantially to the reduction of health data poverty by
improving representation of the diversity within the United States population with the objective of equity in voice
and benefits from healthcare in the United States.

Public health relevance
PROJECT NARRATIVE This project will advance public health by developing new CAHPS survey items targeted at underserved groups of the U.S. population, evaluate alternative methods of data collection designed to improve response rates, enhance the collection and analysis of patient narrative reports about health care, and assess the impact of CAHPS surveys and reports on quality improvement efforts and patient experiences with care. We will use a health equity focus to better represent and enhance the experiences of care for traditionally underserved patients: racial/ethnic minorities, those with Spanish-language preference, and those with functional limitations. The products include new targeted items, updates to the standard CAHPS health plan and clinician and groups surveys, information about optimal data collection methods, methods to minimize bias in analyzing patient narrative data, and quality improvement demonstrations that improve patient care and promote equity.